Endothelial-Derived Signatures of Neurodegenerative Progression

PROJECT SUMMARY/ABSTRACT
Amyotrophic Lateral Sclerosis (ALS), Frontotemporal Dementia (FTD) are devastating progressive
neurodegenerative diseases characterized by neuronal dysfunction and loss. Dysfunction of the
vascular endothelium precedes and likely contributes to cognitive decline by impairing blood-brain
barrier (BBB) integrity. However, the exact timing of endothelial dysfunction, neuroinflammation,
and cognitive decline has not been determined, in part due to the challenges associated with
reliably detecting and characterizing endothelial changes in vivo. Our lab identified a unique
transcriptional state in capillary endothelium, marked by nuclear TDP-43 depletion, in human donors
with ALS-FTD. TDP-43, encoded by the TARDBP gene, is an RNA-binding protein implicated in both
familial and sporadic forms of ALS-FTD. Nuclear loss of TDP-43 leads to pathological protein
aggregation. Mouse models of nuclear TDP-43 depletion show endothelial dysfunction and increased
BBB permeability, with significant transcriptional overlap between these models and human patients.
Understanding how vascular alterations, including endothelial dysfunction and BBB
breakdown, evolve during disease progression remains a critical gap. To gain an understanding
of molecular changes preceding vascular dysfunction, this project aims to leverage cerebrovascular
endothelial extracellular vesicles (cEC-EVs) to sample the capillary brain endothelium, given their
unique ability to preserve RNA and protein cargo. In Aim 1, we will identify markers of nuclear TDP-43
depletion in cEC-EVs using a brain endothelial cell-specific TDP-43 deletion mouse model combined
with BirA-mediated biotinylation to selectively isolate brain-endothelial-derived secreted proteins and
cEC-EVs. Complementary in vitro studies will validate EV content via RNA sequencing and
proteomics. Aim 2 focuses on longitudinal characterization of EV composition in a TDP-43 knock-in
mutation mouse model, which partially recapitulates molecular features of human ALS-FTD. These
analyses will assess EV-derived RNA and protein markers as indicators of endothelial dysfunction
across neurodegenerative disease progression. This research seeks to establish a novel approach
for in vivo sampling of the BBB and to establish a timeline linking endothelial dysfunction to
neuroinflammation and cognitive dysfunction. The approaches developed could offer valuable
insights into vascular dysfunction in ALS-FTD and inform future diagnostic strategies.

Public health relevance
PROJECT NARRATIVE Current diagnostic tools for Amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD) are invasive and predominantly detect advanced disease after irreversible neuronal damage has occurred, limiting opportunities for therapeutic intervention, and contributing to poor clinical outcomes. This project aims to develop non-invasive biomarkers based on extracellular vesicles (EVs) derived from cerebrovascular endothelial cells to enable early detection of cerebrovascular dysfunction, a key feature of these diseases. By identifying and characterizing EV markers associated with TDP-43 proteinopathy—a hallmark of ALS and FTD—this work has the potential to improve diagnostic precision, enable early therapeutic intervention, and inform disease progression monitoring.